The Relationship Between Brain Macrophages and Cognitive Dysfunction in Systemic Lupus Erythematosus

Northwestern University
PROJECT SUMMARY
Systemic lupus erythematosus (SLE) is a chronic autoimmune disease involving genetic and environmental
factors culminating in multiple detrimental comorbidities. One such comorbidity is the onset of what is referred
to as CNS lupus (NP-SLE). Despite the impact of NP-SLE on health-related quality of life and although numerous
mechanisms have been proposed, none can solely account for NP-SLE pathogenesis. We published that
expression of NP-SLE-specific disease signatures in tissue-resident macrophages in the brain correlates with
the severity of behavioral deficits in two NP-SLE models prior to overt systemic disease. Further, our single-cell
RNA sequencing (scRNA-seq) data identify homeostatic and disease-associated states in tissue-resident
macrophages of aged control and NP-SLE-prone mice. However, the disease-associated macrophage subset
in NP-SLE is depleted for genes associated with phagocytosis, which is in contrast to their known phagocytic
role in other diseases. We also find that restricted expression of the disease-associated transcriptional program
in NP-SLE tissue-resident macrophages corresponds to improved behavioral outcomes in NP-SLE-prone mice
following treatment with fingolimod. These discoveries mark the first to implicate this disease-associated tissue-
resident macrophage subset as a potentially pathogenic population in NP-SLE, which contrasts with their
proposed protective role in the literature. We hypothesize that pathogenic disease-associated tissue-
resident macrophages in the brain are crucial for NP-SLE development and targeting this population
may represent a new therapeutic avenue for treating NP-SLE. In Aim 1, we will determine whether tissue-
resident brain cells or infiltrating immune cells are required for NP-SLE using reciprocal head-shielded bone
marrow chimeric mice of WT and NP-SLE-prone donors and recipients. We will test whether blocking transition
from the homeostatic state to the disease-associated state via deletion of TREM2 (a critical functional regulator
of this population) in tissue-resident macrophages prevents NP-SLE. We will delineate the role that type I
interferon (IFN) plays in the development of NP-SLE-like disease by examining the role for the upstream receptor
(IFNAR) and downstream signaling protein IFN regulatory factor 5 (IRF5), which have been linked to SLE
susceptibility, via deletion of these signaling mediators in tissue-resident macrophages. We identified a cell
subset in human cerebrospinal fluid (CSF) that transcriptionally resembles disease-associated tissue-resident
macrophages. Moreover, classical monocytes can repopulate a compromised tissue-resident macrophage niche
and we see numerical expansion of these cells in NP-SLE models. In Aim 2, we will obtain paired CSF and
peripheral blood (PB) from SLE patients with and without NP-SLE for transcriptional profiling of CSF
macrophages and PB monocytes to correlate with clinical outcomes. Despite investigation of tissue-resident
macrophages in the brain in other disciplines, we will be the first to examine their role in NP-SLE. These data
will be invaluable for downstream development of improved diagnostics or targeted therapies.

Public health relevance
Northwestern University PROJECT NARRATIVE As diagnosis of neuropsychiatric systemic lupus erythematosus (NP-SLE) is a challenge due to the lack of definitive causal mechanisms underlying disease, our proposed use of multiple mouse models of NP-SLE, including our novel Caspase-8 Removed CD11c-specific Overactive MyD88 (CReCOM) model, as well as patient blood and cerebrospinal fluid samples, has the potential to deliver innovative and transcending mechanisms for brain-resident macrophage-specific control of NP-SLE pathogenesis not feasibly achieved via in vitro analyses. Since diagnostic strategies for NP-SLE are limited, patients with NP-SLE often fail to achieve remission using current therapies and side effects from treatment are substantial, the ultimate objective is to utilize these research discoveries to help in the development of targeted laboratory diagnostic tests as well as safer, more effective therapies for NP-SLE.